Machine Learning for Ventricular Arrhythmias

Project Summary
Ventricular tachycardia (VT) and fibrillation are leading causes of cardiac arrest, dizziness,
syncope and hospitalization in the United States and worldwide. However, the management of patients
at risk for VT remains suboptimal despite scientific discoveries from basic to population science. In
particular, there is no framework to estimate which patients with VT are likely to respond to anti-
arrhythmic medications or ablation. Therapy is thus empirical. There is great excitement to use analysis
of “big data” to personalize VT therapy, but this has not yet improved outcomes.
This project develops a novel computational approach to personalize VT therapy that combines
machine learning in large registries with computational models. Machine learning will be applied to data
across biological scales that span bedside, laboratory and non-invasive imaging, to predict which
patients are likely to respond to therapy. Computer models will be used to estimate if a given patient's
heart is likely to support VT before versus after therapy. We will validate results in large external
registries from different Institutions. We have 3 specific aims: (1) To develop a computational pipeline to
predict response to VT ablation using bedside, laboratory and non-invasive imaging; (2) To use machine
learning of clinical data and non-invasive imaging to identify which patients with VT will respond to anti-
arrhythmic medications in a large database; (3) To combine computational approaches to estimate the
relative likelihood that a given patient will respond to various forms of therapy. Results from each Aim will
be tested in independent external registries. We will probe computational models to identify clinical
phenotypes that could be applied at the bedside.
This project will provide immediate clinical impact for patients with VT. We will combine machine
learning with physics-based computer models in large registries at Stanford and External centers. We will
reduce computational bias using FAIR methods (Findable, Accessible, Interoperable, and Reusable),
and make tools freely available per the 2018 NIH Strategic Plan for Data Science. Our team comprises
experts in clinical and basic electrophysiology, imaging, machine learning, bioengineering and statistics.
The project is very feasible.

Public health relevance
Narrative The heart rhythm disorders of ventricular arrhythmias affect hundreds of thousands of individuals in the U.S. alone and are substantial causes of mortality, yet their therapy is suboptimal. A major problem is that it is difficult to identify which patient will respond to drug or ablation therapy. This project will develop a computer-based framework to personalize therapy for ventricular tachycardia, using machine learning and personalized computer models.